Development of a novel therapy with Apolipoprotein E for osteogenesis imperfecta

Osteogenesis imperfecta (OI), known as a brittle bone disease, is a genetic disorder typically caused by a mutation in type l collagen. In addition to bone fragility, growth deficiency is a critical musculoskeletal issue of OI. There is no cure for OI. While bisphosphonates are the standard treatment to strengthen bones, there is no reliably effective treatment for growth impairment, especially in patients with severe types of OI. Previously, we and others have reported that systemic infusion of mesenchymal stem/stromal cells (MSC) can stimulate bone growth in OI patients as well as in OI model mice. Despite this striking growth acceleration, the therapeutic effects were transient. Moreover, MSC therapy has several inherent limitations such as inconsistent results between different MSC donors, need for Good Manufacturing Practice facilities, and safety concerns of culture- expanded cellular infusions. Thus, identifying the mechanism of MSC-induced bone growth is critical to develop novel cell-free therapies that can be safely and repeatedly implemented during the growth period in OI patients. Our investigation revealed that MSC-induced bone growth was not a direct effect of MSCs themselves; rather, MSC infusion induced production of a factor(s) in the serum which stimulated chondrocyte proliferation in the growth plate and resulted in linear bone growth. Proteomic and bioinformatics analyses of the serum from MSC infused mice identified apolipoprotein E (ApoE) as a primary candidate for the factor. Our preliminary studies demonstrated that ApoE serum levels were significantly elevated after MSC infusion and recombinant ApoE markedly stimulated chondrocyte proliferation and hypertrophic differentiation in chondrocyte culture. Moreover, ApoE enhanced bone growth in ex vivo organ culture. These findings were strongly supported by compelling evidence that ApoE knockout mice display significantly shorter bones than wild type mice. Collectively, these findings provide rigorous premises for our highly innovative hypothesis that ApoE can improve bone growth deficiency by stimulating chondrocyte proliferation and differentiation in the OI growth plate. Additionally, it has been shown that ApoE is produced by mature osteoblasts. In OI, mutated Col1 expression prevents osteoblasts from maturation and as a result, the number of mature osteoblasts is significantly reduced. Interestingly, our preliminary study showed that ApoE levels in bones were significantly lower in OI mice than wild type controls. These findings suggest that reduced production of ApoE by OI osteoblasts may play a critical role in the pathogenesis of OI growth deficiency. Thus, we propose the following specific aims: (1) to determine the therapeutic effects of ApoE for growth deficiency in OI; and (2) to examine the role of ApoE produced by osteoblasts in growth plate function and bone growth. The completion of these aims will determine whether ApoE can serve as a novel therapeutic molecule to enhance bone growth in OI and provide novel insights to identify the pathogenesis of OI growth deficiency. This exploratory project has the potential to completely revolutionize the treatment strategy for OI.

Public health relevance
PROJECT NARRATIVE Short stature is a major symptom of osteogenesis imperfecta (OI), a genetic bone disorder; however there is no reliably effective treatment to address this growth deficiency. In this proposal, we will determine whether Apolipoprotein E improves bone growth in a murine model of OI and whether Apolipoprotein E derived from osteoblasts plays an important role in growth plate function and bone growth. The outcome of the proposed studies will provide novel insights to identify the mechanism of growth deficiency in OI and lead to the development of novel treatments.